Using Atrial Mechanics To Identify Fibrosis In Patients with Atrial Fibrillation

PROJECT SUMMARY
Atrial fibrillation (AF) is a highly prevalent disease affecting 5.2 million Americans, costs the US $6-26 billion per
year, and increases the risk of cardiovascular disease, stroke, and death. Selecting the optimal treatment for
each AF patient remains a daily clinical challenge as no single treatment is best in all cases. Symptomatic
patients are most frequently treated pharmacologically, or by catheter ablation to isolate or destroy aberrant atrial
tissue. However, both are commonly ineffective and there are no consistent predictors of response.
Pathological atrial fibrosis is a major contributor to sustaining AF, has repeatedly been implicated in its
pathogenesis and is proposed as a biomarker for personalizing treatment. We propose to use cardiac MRI (CMR)
mechanics-based measures to identify localized atrial fibrosis. Atrial fibrosis fosters chaotic electrophysiology
and also attenuates local atrial mechanics, decreases contractility, and increases stiffness. The impact on atrial
mechanics is substantial. Therefore, we hypothesize that attenuated atrial mechanics provide a robust measure
of atrial fibrosis. The result of this project will be the first histologically validated, reproducible and repeatable
clinical tool that enables estimation of atrial fibrosis burden.
The aims of this grant will exploit the mechanistic link between atrial fibrosis and atrial mechanics to develop
and validate a clinical workflow for measuring a mechanics-based classifier of fibrosis. The overall objective is
to establish a mechanics-based and discriminatory measure of histologically validated atrial fibrosis. The
following aims are designed to achieve this objective.
AIM 1. To robustly measure 3D atrial CMR strain and stiffness in sinus rhythm and AF. Atrial motion – even
during AF – is readily apparent on CMR. Our free-breathing and arrhythmia insensitive CMR protocol enables
measuring atrial mechanics without the need for contrast or the limitations of echocardiography, nor the radiation
of CT. We seek to detect atrial fibrosis by identifying impaired atrial mechanics.
AIM 2. Validate and benchmark a CMR mechanics-based classifier of atrial fibrosis. The optimal index for
identifying local atrial fibrosis from atrial mechanics is not known. Training and validating a classifier requires a
ground truth, which we will measure directly using histology. The classifier will then be benchmarked against
conventional markers of atrial fibrosis (voltage mapping and LGE-CMR).
Public Health Significance – Identifying patients with atrial fibrillation (AF) that will respond to specific treatment
strategies such as ablation is a daily challenge for cardiologists. Selecting the optimal treatment for each AF
patient remains an open challenge. The results of this work will enable clinicians to better manage patients with
atrial fibrillation by helping to identify the atrial fibrosis burden using cardiac MRI based methods.

Public health relevance
PROJECT NARRATIVE Atrial fibrillation (AF) affects over 5 million Americans, costs the US $6-26 billion per year, and increases the risk of cardiovascular disease, stroke, and death. Selecting the optimal treatment for each patient remains a daily clinical challenge as treatments are frequently ineffective. Atrial scarring (fibrosis) is one of the key processes that instigate AF and has been shown to predict treatment success. However, there is no firmly established method for measuring atrial fibrosis. We propose to use magnetic resonance imaging (MRI) of atrial mechanics to identify localized fibrosis and hypothesize that attenuated mechanics provide a robust measure of atrial fibrosis.